Promoting Engagement in the Drug Resistant TB/HIV Care Continuum in South Africa

? DESCRIPTION (provided by applicant): Tuberculosis (TB) remains the leading cause of morbidity and mortality worldwide among people living with HIV. Globally, the incidence of multidrug-resistant tuberculosis and extensively drug resistant tuberculosis, the most drug-resistant forms of TB, has approximately doubled over the past fifteen years. Nowhere has this increased incidence generated more concern than South Africa where interactions between TB and generalized HIV/AIDS epidemics are causing `explosive' TB incidence and case-fatality threatening to undermine the progress reached with antiretroviral therapy (ART). Medication adherence, a key predictor of outcomes in multi-and extensively drug-resistant TB (M/XDR-TB) and HIV treatment, is understudied in high burden TB/HIV settings. Patient losses during transitions in the TB/HIV care continuum are frequent and lead to increased mortality. Demands of M/XDR-TB HIV treatment are severe including extraordinary pill burden, severe adverse effects, lengthy treatment, isolation, and stigma, with few parallels in modern medicine. The goal of the proposed study is to enhance adherence and retention in care for M/XDR- TB HIV patients in South Africa through a community-based strategy, including use of community adherence groups, with the overarching goal of promoting patient engagement in a continuum of M/XDR-TB HIV care. Although well established for ART, this is the first application of a community adherence group intervention to an M/XDR-TB HIV co-infected population. To achieve this goal, we will characterize critical implementation gaps in our understanding of adherence to treatment for drug-resistant TB and HIV, use this data to inform an evidence and theory-based intervention to improve adherence and promote retention in care, and rigorously evaluate the intervention with a mixed methods approach using quantitative clinical outcomes and qualitative understanding of impact on barriers and facilitators At the conclusion of these studies we will have addressed critical gaps in our understanding of adherence to treatment for drug-resistant TB and HIV, evaluated the potentially predictive value of novel adherence measures and assessed the impact of an exploratory, culturally acceptable, and patient-oriented intervention to support adherence.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tuberculosis (TB) is the leading cause of death worldwide among people living with HIV/AIDS, and drug-resistant TB HIV is increasing in South Africa. Medication adherence and retention in care are critical components of the care continuum and predict TB cure and survival. This proposal seeks to understand local barriers and determinants for adherence and retention in South Africa, implement an innovative community-based intervention, and evaluate the effect of the intervention on clinical outcomes and patient barriers to adherence and retention.